Pathologic consequences of epidermal lipase deficiencies

PROJECT SUMMARY/ABSTRACT
The biological function of skin enriched lipases (epidermal lipases) K, M and N are not defined. Some people
with autosomal recessive congenital ichthyosis harbor disease associated Lipase N mutations, suggesting a
clinically relevant role for this protein in skin health. In addition, our recent work indicates lipase M is critical for
skin development and function and that epidermal lipase transcripts are reduced in a chronic lesion of atopic
dermatitis. These observations suggest epidermal lipases M, N, and, potentially, K, are important for skin
development and that defects or deficiencies of one or more of these proteins may contribute to some types of
ichthyoses and atopic dermatitis. In light of these observations, the primary goal of this research is to use novel
experimental systems to understand the biological consequences of epidermal lipases K, M and N deficiency in
skin development and function. The proposed studies will use human skin equivalents lacking expression of
individual epidermal lipases (Aim 1) and an inducible lipase M conditional knock out mouse model (Aim 2) to
understand the pathologic consequences of epidermal lipase deficiencies. Understanding the consequences of
epidermal lipase deficiencies may provide insights into the molecular functions of these proteins and could lead
to novel therapies for inherited ichthyoses and atopic dermatitis.

Public health relevance
PROJECT NARRATIVE: Impaired skin development and barrier function significantly impact health and quality of life in patients with inherited ichthyoses and atopic dermatitis. The primary objective of this work is to understand how deficiencies in three skin enriched lipases (epidermal lipases) affect skin development and skin barrier function. Understanding the consequences of epidermal lipase deficiencies may provide insights into the molecular functions of these proteins and could lead to novel therapies for inherited ichthyoses and atopic dermatitis.